EphA2 in Non-Alcoholic Fatty Liver Disease

PROJECT SUMMARY
Non-alcoholic fatty liver disease (NAFLD) is characterized by hepatic steatosis driven by enhanced free fatty
acid (FFA) uptake and lipid synthesis with reduced lipid clearance through mitochondrial fatty acid oxidation and
lipoprotein export. Excessive hepatic lipid accumulation can cause lipotoxicity, which promotes local
inflammation, hepatocyte ballooning, and fibrosis. This process leads to the development of nonalcoholic
steatohepatitis (NASH), that can further progress to cirrhosis, liver failure, or hepatocellular carcinoma if left
unchecked. Current treatments for NAFLD/NASH seek to either reduce hepatic steatosis or diminish the fibrosis
response that drives NASH development. While these treatments have shown great promise in pre-clinical trials,
they have yet to provide a clear therapeutic benefit.
The Eph family of receptor tyrosine kinases, the largest family in the mammalian genome, interact with Eph
receptor-interacting (ephrin) ligands on adjacent cells to mediate cell adhesion/repulsion signaling during axonal
guidance, tissue patterning, leukocyte homing, and metastasis. Differential ligand-dependent and ligand-
independent phosphorylation events appear to mediate these often-inverse functions of EphA2 signaling. EphA2
interactions with ephrinA1 on an adjacent cell promote tyrosine autophosphorylation (Y588, Y772) and intrinsic
kinase activity, resulting in the inhibition of proliferation and migration. In the absence of ligand, EphA2 can
become phosphorylated on S897, classically by Akt, resulting in enhanced proliferation and migration through
largely unknown mechanisms. Work from our lab demonstrated EphA2 expression in multiple cell types and
EphA2 deletion reduces atherosclerotic plaque formation. Our preliminary data show that EphA2 knockout mice
show significantly reduced liver weight/body weight ratios following high fat diet feeding associated with
diminished hepatosteatosis and reduced inflammation. Furthermore, C57Bl/6J mice treated with a high fat diet
for 8 weeks show enhanced expression of the EphA2 ligand ephrinA1, along with enhanced markers of EphA2
ligand-dependent signaling. In contrast, both NASH patients and mouse models of NASH show decreased
ephrinA1 expression and enhanced markers of EphA2 ligand-independent signaling. Therefore, we
hypothesize that ligand-dependent EphA2 signaling serves as an initial protective mechanism in early
NAFLD that weakens as the disease progresses. Using a combination of cell culture and mouse models,
we will determine the role of EphA2/EphrinA1 expression and signaling in lipid homeostasis and metabolism
(Aim 1), and determine the role of EphA2/EphrinA1 expression and signaling in NAFLD/NASH progression (Aim
2). If successful, these studies will elucidate a novel role for EphA2 signaling in NAFLD/NASH pathogenesis and
may provide a novel therapeutic target to reduce liver damage in NAFLD/NASH.

Public health relevance
PROJECT NARRATIVE: Non-alcoholic fatty liver disease (NAFLD), characterized by abnormal hepatic lipid accumulation, hepatocyte ballooning, inflammation, and fibrosis, is the leading cause of liver failure in the world, affecting 25% of the global population. Our work has uncovered a novel role for the receptor tyrosine kinase EphA2 in NAFLD, with potential implications in late stage NASH Therefore, this project may identify a new therapeutic target for the treatment of NAFLD.